Identifying the neural mechanisms of goal-directed decision-making in Parkinson's disease using closed-loop deep brain stimulation

TITLE: IDENTIFYING THE NEURAL MECHANISMS OF GOAL-DIRECTED DECISION-MAKING IN
PARKINSON’S DISEASE USING CLOSED-LOOP DEEP BRAIN STIMULATION
PROJECT SUMMARY
People with Parkinson’s disease commonly suffer from non-motor symptoms, including motivation deficits, that
impact quality of life more than classical motor symptoms and are exacerbated by current treatments like
dopaminergic drugs and deep brain stimulation. The long-term goal of this research is to understand the neural
basis of motivated decision-making to develop new therapies that can re-tune reward networks and address
this therapy gap. The overall objective of this proposal is to identify the neural signals that implement top-down,
goal-directed control of choices and their causal role in decision-making. My central hypothesis is that theta
frequency activity in the basal ganglia is required for implementing top-down control over decisions, and that
inhibiting the basal ganglia with closed-loop neurostimulation based on theta activity will reduce goal-directed
decision-making. Therefore, the rationale of the project is that identifying the neural signals underlying goal-
directed decision-making and causally manipulating them in a reward learning paradigm will reveal biomarkers
that can be used to re-tune these circuits and treat behavioral disorders. The central hypothesis will be tested
by pursuing two Specific Aims: Aim 1) Identify spatially and spectrally specific neural network signals for goal-
directed decision-making. We will record chronic frontal cortical and basal ganglia activity using
electrocorticography and sensing-enabled deep brain stimulation devices implanted in patients with
Parkinson’s disease while they perform a reward learning task. We will quantify choice strategies using
reinforcement learning models and relate goal-directed decision-making to neural signals, both ON and OFF
dopaminergic medications. Aim 2) Test the causal role of theta in goal-directed decision-making using closed-
loop brain stimulation. We will trigger inhibitory deep brain stimulation in the basal ganglia when theta power is
high to disrupt goal-directed decisions, thereby establishing the causal role of theta in top-down control of
decision-making. The research is innovative because it will be the first to use chronic, multi-site, invasive
electrophysiology and closed-loop brain stimulation to establish causal relationships between specific neural
signals and goal-directed decision-making in humans. It is significant because it will lead to biomarkers to
guide diagnosis and treatment of motivation deficits in patients with Parkinson’s disease and other
neuropsychiatric conditions. Dr. Hoy has assembled an interdisciplinary team of mentors led by Dr. Simon
Little and supported by Drs. Philip Starr, Wouter Kool, and Winston Chiong. Together, they have designed a
comprehensive training plan involving (1) closed-loop deep brain stimulation and subcortical neurophysiology,
(2) reinforcement learning computational modeling, (3) neuroethics, and (4) professional development. This
fellowship will facilitate Dr. Hoy’s evolution into a leader in reward neuroscience and invasive human
neurotechnology. It will also prepare him to develop a K award grant application as a means to transition into
an independent academic researcher.

Public health relevance
PROJECT NARRATIVE Deficits in motivation are disabling features of numerous neuropsychiatric disorders including Parkinson’s disease, but a lack of understanding of dysfunction in human reward circuits prevents the development of effective treatments for these conditions. The goal of this project is to use novel sensing-enabled deep brain stimulation devices and computational reward learning models to identify the neural circuits underlying healthy and unhealthy goal-directed decision-making, as well as to test their causal role in behavior via closed-loop neurostimulation. Delineating the neural mechanisms of goal-directed decision-making in humans will uncover fundamental neurobiology of reward processing and provide biomarkers that can optimize the diagnosis, treatment, and prevention of motivation dysfunction in Parkinson’s disease and other neuropsychiatric disorders.